Administrative Core: Coordinating and collaborating to facilitate VCC work

Project Summary- Administrative Core
The Virome Characterization Center (VCC) aims to fulfill NIH's mission by extensively characterizing the
human virome – the collection of all the viruses that are found inside and on the human body – in varied
human cohorts, leveraging advanced genomic technologies, bioinformatics, and computational analyses. This
ambitious project involves a collaborative effort, utilizing advanced genomic technologies, bioinformatics, and
computational analyses.We have established an Administrative Core (AC) to bring expertise in managing
large-scale consortia and genomics programs, particularly microbial research for public health. The AC’s
objectives include providing leadership, administrative oversight, and coordination among VCC cores to ensure
efficiency and productivity, aligning with the program's goals and milestones. Collaborations with other Human
Virome Program (HVP) sites and National Institute of Health (NIH) officials will improve Consortium operations,
standardize protocols, and share resources, enhancing human virome analysis standards globally. The AC
team is also committed to integrating Diversity, Equity, Inclusion, and Accessibility (DEIA) values throughout
their processes.Under Aim 1, the AC will establish leadership and practices to support the VCC and HVP.
The leadership team, experienced in managing research consortia, will focus on coordinating across cohorts
for virome characterization, emphasizing DEIA values. They will oversee VCC's progress, employing
collaborative decision-making and a "Disagree and Consent" method for conflict resolution, ensuring alignment
with program goals and integration of pilot project results into VCC outputs.They will further ensure resilience
through the support of a Scientific Advisory Board (SAB), designated arbiter, and succession plan. Aim 2
involves organizing and managing interactions within VCC cores. The AC will lead the VCC, coordinating
cores, ensuring clear communication, and defining responsibilities in terms of person-months. They will also
manage the VCC's scientific and administrative progress with a milestone-based plan, facilitate effective
communication and collaboration, ensure financial oversight, and collaborate with the Data Analysis and
Submission Core (DASC) to minimize confounding research variables. Finally, under Aim 3, the AC will focus
on enhancing Consortium operations and sharing protocols, resources, and training throughout the HVP. They
will enable access to data, publications, and technology, ensuring open access and transparent, ethical
practices in biospecimen and data sharing. The AC will also support training and collaboration, bolstering
research capabilities through training programs and workshops, enhancing collaboration with other VCCs, and
establishing working groups for material refinement and a centralized digital repository for SOPs and other
materials. This comprehensive approach aims to elevate the overall quality and impact of human virome
research nationally and globally.

Public health relevance
Project Narrative: Administrative Core: The Virome Characterization Center (VCC) aims to extensively characterize the human virome – the collection of all the viruses that are found inside and on the human body – using advanced genomic technologies and computational analyses, contributing to a deeper understanding of virus-host interactions and their impact on human health. The Administrative Core (AC) will ensure efficient operation and coordination among four cores across sample collection, genomic characterization, data analysis, and ethical, societal, and legal implications, to enhance the quality and productivity of virome research. Additionally, the VCC's collaboration with other Human Virome Program (HVP) sites and NIH officials, alongside its commitment to Diversity, Equity, Inclusion, and Accessibility (DEIA) values, strengthens its potential to advance global standards in human virome analysis, thereby influencing public health strategies and responses to viral diseases.